Statistical Methods for Precision Prevention

PROJECT SUMMARY/ABSTRACT
Prevention holds the greatest potential for reducing cancer burden in the population. Recent
breakthroughs in genomics technologies have propelled advancements in deciphering molecular events and
understanding cancer causes, leading to improved risk stratification and precision prevention. The objective of
this application is to develop statistical and computational approaches to harness state-of-the-art genomic data
and translate these findings into precision prevention through risk-based intervention strategies.
Tumors are heterogeneous and unraveling tumor heterogeneity to distinguish indolent versus
aggressive tumors will facilitate the understanding of underlying disease process. Emerging spatial omics
technology, which simultaneously profiles both molecular features and spatial locations, provides critical
information about the tissue microenvironment essential for understanding disease development. There are
significant challenges in analyzing such data, including non-comparability of spatial omics images from
different samples, high-dimensional data, and limited sample size. The goal of Aim 1 is to develop (a) deep
learning-based approaches that combine unsupervised and supervised loss functions for learning common
features predictive of poor clinical outcomes and (b) robust and efficient data integration approaches for
assessing the association of individual's risk factors with these features, leveraging external existing biomarker
summary information to improve efficiency while accounting for data source heterogeneity.
Identifying risk factors that are associated with tumor subtypes linked to adverse outcomes can better
stratify the population into different risk levels, enabling tailored prevention approaches such as determining
when to start screening. This requires careful cost-effectiveness analysis using large-scale observational data.
However, analyzing such data is complex due to non-random utilization of intervention and confounding.
Further, the timing of screening is continuous and subject to censoring, as some individuals may have died or
been diagnosed with the disease before initiating screening. The goal of Aim 2 is to develop statistical
methods for assessing the cost-effectiveness analysis of time-varying screening, including (a) a causal-
inference-based estimation procedure to quantify the benefit and cost of the intervention; (b) leveraging
improved risk prediction from Aim 1 to determine “when to start screening” based on its impact on the benefit
and cost in the population.
Through our collaboration, we will apply the methods to data from the Genetics and Epidemiology of
Colorectal Cancer Consortium to gain insight into carcinogenesis and risk assessment and evaluate their
translational impact in the Women's Health Initiative cohort. Since our methods are also applicable to other
studies, we will develop R or python-based open-source software packages, along with detailed manuals and
data processing pipelines. These resources will be made available in public repositories or on our websites.

Public health relevance
PROJECT NARRATIVE Prevention has been long recognized as an important approach in reducing the cancer burden on individuals and on the population. Recent advancements in genomics technologies have enabled the deciphering of molecular events in tumors and their microenvironment in great detail, the progress of which has paved the way for better identification of cancer causes and improved risk stratification. The objective of this application is to develop statistical and computational approaches to harness state-of-the-art genomic data and translate these findings into precision prevention through risk-based intervention strategies.